1/2- Feasibility study to build a collaboration in genetics and genomic cancer research

Project Summary
This is a partnership between Hampton University (HU) and the Tisch Cancer Institute (TCI) at
the Icahn School of Medicine at Mount Sinai that seeks to establish robust collaborations on-site
and online training and education to increase HU faculty's research capacity in the area of
genetics and genomics and health disparities, while increasing TCI research in health disparities,
using the examples of prostate and breast cancer. The final goal is to create a competitive and
sustainable joint Center for Genetics and Genomics Cancer Research, encompassing the
genetics and genomics aspects of health disparities to explain population differences in breast
and prostate cancer occurrence and outcome.
The proposal is grounded in a longstanding and productive undergraduate educational
collaboration between faculty at these two institutions, but is distinct in its focus, methods, and
goals. Hence, the proposed program will utilize the best practices learned from previous
collaborative endeavors to inform and create an innovative platform which will enhance research
capacity at both institutions while addressing key institutional challenges. Our goals will be
accomplished through a series of well-coordinated training/educational activities and two pilot
research projects that were strategically chosen to meet our overarching goals of 1) improving
health outcomes in vulnerable populations, 2) addressing gaps in cancer disparities research, 3)
augmenting genomic, statistics, epidemiology expertise and 4) enhancing investigator
productivity and extramural funding competitiveness.
Training and education will aim to increase HU faculty's research capacity in the area of genetics
and genomics and health disparities, using the examples of prostate and breast cancer. It will
provide TCI ISMMS with access and collaboration to scientific projects in breast and prostate
cancer disparity etiology, treatment and outcome, as well as to a mechanism to increase the
diversity of the genetics and genomics faculty, which has traditionally lacked diversity
To ensure the success of the training and education program, we have assembled an excellent
team of faculty with outstanding mentoring and teaching track records, along with extensive
expertise in developing and implementing new initiatives aimed at diversifying the clinical
investigator workforce and eliminating health disparities. HU faculty will also be exposed to the
most novel and cutting edge methods in cancer genomics through the completion of the pilot
research project.

Public health relevance
Project Narrative This is a partnership between Hampton University (HU) and the Tisch Cancer Institute (TCI) at Icahn School of Medicine at Mount Sinai that seeks to establish robust collaborations through on-site and online training and education to increase HU research capacity in the area of genetics and genomics and health disparities, using the examples of prostate and breast cancer. The final goal is to create a competitive and sustainable joint Center for Genetics and Genomics Cancer Research, encompassing the genetics and genomics aspects of health disparities to explain population differences in breast and prostate cancer occurrence and outcome.